Acquisition of an Additional Mixed CPU/GPU Computational Node at the CUNY HPCC

This is a supplemental proposal to obtain additional computational equipment to be stored in the City University of New
York (CUNY) High Performance Computing Center (HPCC) in support of grant 1R15GM146228-01. The CUNY HPCC
is located at the College of Staten Island, which is the location of the PI. The original proposal focuses on the
development of methods to characterize the structure and dynamics of the nucleosome core particle, focusing on nucleic
acid sequence, posttranslational modifications, and oncogenic mutations. The obtainment of additional computational
equipment at the HPCC is critical to the success of this grant. As discussed in the proposal, the atomistic simulations and
system sizes require access to computational nodes with multiple GPUs (graphics processing units). This grant will
support multiple undergraduate students during the summer and the academic year. Exposure of undergraduate and
graduate students (in Chemistry, Biochemistry, and Computer Science) to advanced computational equipment at the
CUNY HPCC will promote the success of their research projects in computational molecular biophysics.

Public health relevance
This is a supplemental proposal in support of grant 1R15GM146228-01. State-of-the-art simulation and modeling techniques will be used to characterize the structure and dynamics of the nucleosome core particle. Insight gained should characterize the key molecular forces that guide the unwrapping of nucleosomal DNA from the histone core and predict new post-translational modification sites that experimental collaborators can test. Alterations or mutations in the nucleosome core particle have been implicated in cancer and other human diseases. Critical to success of the grant is obtainment of additional computational equipment at the CUNY HPCC (High Performance Computing Center).